Pilot Feasability

PROJECT SUMMARY (PILOT/FEASIBILITY CORE)
The BBDC Pilot/Feasibility Core (PFC) has been successful over the past two cycles of the Brittle Bone
Disorders Consortium (BBDC) in soliciting, reviewing, funding, and reporting on the impact of the pilot studies.
We have engaged both investigators both inside and external to the BBDC. As expected, the results of these
studies have both supported or disproven the underlying hypotheses. Importantly, these pilot studies have
been published and/or contributed to future pilot and/or full projects in subsequent cycles. In addition, the have
been vehicles for early stage investigators and trainees (ESI) to advance their careers in the rare bone disease
(RBD) fields, with some no serving as co-PI of current and proposed projects. We will build on our successful
experience in years 1-10 to continue solicitation, review, funding, and reporting of pilot studies from both inside
and outside the BBDC investigator community for research projects that leverage the BBDC infrastructure and
data. The Specific Aims are to: 1) Cooperate with the Osteogenesis Imperfecta Foundation (OIF), and the
BBDC Career Enhancement Core (CEC), and Administrative Core (AC) to perform outreach to investigators
and trainees both inside and outside of the BBDC; 2) Review, fund, and implement pilot studies solicited from
the scientific community; 3) Report, audit, and evaluate the ongoing and completed pilot studies. The PFC will
report to the BBDC Executive and Steering Committees on the progress and impact of these studies.

Public health relevance
PROJECT NARRATIVE N/A per RFA